Transient Lighting for Fluorescence Image-Guided Surgery

Abstract We will develop a fluorescence image guided surgery (FIGS) system that delivers optimum, background-free performance without the need to turn off or lower room lighting. Fluorescence image-guided surgery (FIGS) is a rapidly evolving field with broad clinical applications, including more efficacious removal of tumors in real-time; however, ambient room lighting contaminates the fluorescence signal emitted from the patient during the surgical procedure. We are applying a new method called transient lighting that utilizes high-power - low duty cycle switched white LEDs for room and surgical field illumination allowing for timed fluorescence capture that is not affected by the room lights. As part of this project OnLume, Inc. will design and test a prototype system for surgical applications.

Public health relevance
Project Narrative Fluorescence image-guided surgery (FIGS) is a powerful technique with many applications, such as determining the extent of a tumor in real-time during surgery, but ambient lighting hinders the effectiveness of the technique and often requires the lights in the operating room to be turned off. We propose to develop and test an ergonomic wide field FIGS system that can operate in a well-lit operating room without compromising sensitivity. This will have a broad impact on public health by allowing for faster surgical procedure times, safer surgeries, and increased adoption of FIGS.